THE OVERALL SCOPE OF THIS REQUIREMENT IS TO SUPPORT AND MAINTAIN THE CURRENT ELECTRONIC PATHOLOGY REPORTING INFRASTRUCTURE, INCLUDING MAINTAINING CONT

The overall scope of this requirement is to support and maintain the current electronic pathology reporting
infrastructure, including maintaining continuity of electronic pathology reporting licenses for the
facilities listed in Attachment 2 “SEER ePath Sites” and to install and maintain new license installations
as required by the NCI to support the SEER program.